Interdisciplinary Bioengineering Research Training in Diabetes

PROJECT SUMMARY
Diabetes is a global heath epidemic affecting >500M people worldwide. Even with rigorous management
increased risk for diabetic complications remains. Bioengineering approaches are providing innovate
technologies that are overcoming the current limitations in diagnostics, treatments and cures for diabetes
and complications. However, there is a shortage of a skilled scientific workforce able to work on these
developments. The University of Colorado is uniquely capable to host this innovative program -
Bioengineering Interdisciplinary Training for Diabetes Research - to train future scientists with the skills and
knowledge to solve existing and future problems in diabetes research and clinical care. This includes worldrenowned
research and clinical programs in diabetes; exceptional engineering research and training
programs; and bioengineering research and training that is fully integrated with the Medical campus. The
primary goals for the next phase of this program are: 1 ). To attract high-quality trainees with
engineering/quantitative backgrounds; 2). To provide in-depth, multi-disciplinary research training for
predoctoral trainees integrating bioengineering and diabetes; and 3). To prepare trainees for transition to
individual fellowships and research careers in academia or industry. To achieve these goals, our research
training follows 3 core principles: a). That a successful bioengineering career requires an intrinsically multidisciplinary
approach, with scientists equipped with skills covering a broad variety of fields; b). That
successful training of these scientists will require constant interactions between trainees and crossdisciplinary
mentors at all levels of research; and c). That developing such scientists requires an institutional
environment with breadth and depth, established interactions between engineering and clinical science, and
faculty committed to this training. This innovative research training program combines didactic and hands
on coursework, lab-based research, clinical experiences and career skills. Research areas focus on true
strengths at the institution in which established interactions between bioengineering and diabetes are
present, including biomarkers and therapeutic interventions for diabetes and complications; immune
engineering; clinical trials; imaging diagnostics for diabetes and complications; and computational methods
for diabetes management and artificial pancreas. We achieved excellent outcomes during the previous
funding period, including recruiting high quality trainees; trainees publishing extensively and receiving
fellowships; and graduating and continuing into research careers. These outcomes; the depth of expertise in
diabetes and engineering research; the significant institutional support; and the extensive facilities available
make a compelling argument to continue to fund such a program at the University of Colorado.

Public health relevance
NARRATIVE Diabetes is a global heath epidemic, and bioengineering approaches and new technology are needed to advance the development of effective diagnostics, management strategies and cures for diabetes. However there is a shortage of a skilled scientific workforce able to work on these developments, due to the unique training required. We will leverage the outstanding previous experience, expertise, resources and institutional support at the University of Colorado to develop such a training program, in order to attract and train outstanding PhD students, to prepare them for outstanding research careers in academia and industry.